Stem cells for craniofacial bone repair and regeneration

Abstract
The objective of this proposal is to study newly identified stem cells essential for craniofacial skeletal
development and disease. Large bone defects caused by various conditions, e.g. cancer surgery, congenital
malformation, trauma and progressive deforming diseases, are major health issues. Over 2.2 million cases
worldwide each year have to be addressed in the diverse fields of orthopedic, plastic and oral surgeries. The
only solution for such extensive injuries or non-healing issues is to undergo a reconstructive operation.
Current gold standard is to perform autograft that requires transferring bones taken from other parts of the
body to the repair site. However, bone grafts are encumbered by numerous disadvantages, including donor
site morbidity, limited bone supply and complications of extended operating time. The success of such
reconstructions also remains highly challenging owing to a number of limitations. This leads to exploration of
alternative approaches, especially stem cell-based therapy. However, the lack of knowledge regarding stem
cells specific for craniofacial skeletogenesis greatly restricted further advancement. Formation of the
craniofacial skeleton is mainly mediated through intramembranous ossification, a process distinct from
endochondral ossification in the body skeleton. Therefore, skeletal stem cells identified for the long bone may
not be suitable for reconstruction of the craniofacial bones. Using state-of-the-art mouse genetic models, a
recent groundbreaking work from our laboratory has successfully isolated adult skeletal stem cells, residing in
the suture mesenchyme and responsible for formation and maintenance of the craniofacial bones. Upon injury
these suture stem cells react quickly and contribute directly to bone repair by replacing the damaged tissue.
Animal experiments further demonstrated that the injury-induced healing process is greatly facilitated with
transplantation of these naïve cells. Although our findings promise their future use in cell-based therapy and
tissue engineering, there is an urgent need to understand the characteristics of these stem cells for
regenerating craniofacial bone structures. Here our goal is to first perform in-depth evaluations on suture stem
cells in animal models. We will further investigate their role in craniofacial bone development and disease, and
elucidate the underlying skeletal repair and regeneration mediated by suture stem cells. We will emphasize
characterizing their innate ability to regrow craniofacial bone structures. Next, to move a step closer to clinical
applications, we plan to study the corresponding human stem cells and characterize their self-renewal, clonal
expansion, proliferation, and differentiation abilities. This proposal has outstanding potential to advance the
field of regenerative medicine. By studying human cells, we are closer to translating our findings for clinical
use, improving reconstructive surgical repair, and maximizing the benefits of regenerative medicine.

Public health relevance
Narrative This proposal investigates newly identified and isolated skeletal stem cells essential for calvarial bone development, homeostasis and injury repair, as well as their regenerative ability in cell-based therapies. Using genetically modified mouse models and in vitro stem cell culture systems, we will elucidate the mechanisms by which skeletogenic signals sustain the pluripotency of these stem cells, regulate self-renewal, proliferation and differentiation. The results obtained in our study are highly relevant to the health of the human skeleton and has outstanding potentials to advance our knowledge of craniofacial bone biology, leading to novel strategies for reconstruction of large bone defects.